TIM-4 Signaling in NASH Liver Transplant Ischemia/Reperfusion Injury

PROJECT SUMMARY/ABSTRACT
Liver ischemia-reperfusion injury (IRI), resulting from the retrieval of donor organs, cold storage, and warm
ischemia during the surgery, remains to be one of the main causes of morbidity and mortality in clinical orthotopic
liver transplantation (OLT). Liver steatosis, the hallmark of Nonalcoholic fatty liver disease (NAFLD) and
nonalcoholic steatohepatitis (NASH), is observed in approximately 50% of deceased organ donors. Hepatic
steatosis exacerbated hepatic IRI continues to be one of the major risk factors leading to primary graft
dysfunction (PGD) in human OLT. Previous study has shown that stressed hepatocellular phosphatidylserine
(PS) presentation induced endogenous TIM-4 expression on macrophages, which is essential for macrophage
activation/phagocytosis, and further hepatocellular damage in liver IRI. The preliminary study has revealed that
TIM-4 signaling is critical for foamy macrophages-mediated hepatocellular deterioration in NASH liver IRI.
Hypothesis: TIM-4 signaling at the foamy macrophage (innate immune) regulates innate immune response
(pathogenic), phagocytotic reprogramming (phagocytosis), hepatocellular damage (oxidative) and lipid
dynamics (metabolic) during IR-stress in cold-stored murine OLTs. The following two specific aims are proposed:
Aim 1: Determine whether TIM-4 derived-foamy macrophage in NASH liver graft is a risk factor for
developing PGD in cold-stored murine OLTs? Aim 1 will expand upon the preliminary data using genetically
modified mice (TIM-4M-KO, myeloid (macrophage) specific knockout of Timd4 gene) to evaluate pre-OLT and
post-OLT TIM-4 expression on hepatic steatosis mediated-foamy macrophages in relation to PGD events in a
clinically-relevant mouse model of extended hepatic cold storage followed by OLT.
Aim 2: Define molecular mechanisms by which TIM-4 signaling controls foamy macrophage function
in NASH liver IR-stressed OLTs. Hypothesis: TIM-4 activation promotes macrophage IRGM1 in NASH liver IRI
by coupling cyclic GMP-AMP synthase (cGAS) and interferon regulatory factor 3 (IRF3), which in turn potentiates
NASH liver IRI by enhancing pro-inflammatory innate responses. Aim 2 will screen for TIM-4-mediated IRGM1
promotion in NASH IRI-OLTs. Then, a new model of liver IRI in CD11b-DTR mice in which adoptive transfer of
distinctive foamy-macrophage populations (after conditional depletion of native CD11b+ cells) will be utilized to
dissect TIM-4–IRGM1 cross-regulation in hepatic IR-inflammation.

Public health relevance
PROJECT NARRATIVE This project will investigate the mechanisms that TIM-4 mediated foamy macrophage is an important driver of NASH graft injury and development of PGD in IR-stressed syngeneic mouse liver transplants. We will focus on molecular mechanism by which TIM-4 signaling controls foamy macrophages in NASH liver IR-stressed OLTs. Understanding the regulatory mechanisms of TIM-4 signaling at the immuno-metabolism interface in NASH liver IRI should provide a novel therapeutic approach in organ transplant recipients.